Transformative approaches to rapidly and efficiently test demand creation interventions to promote HIV retesting in adults at increased risk of HIV

Project Summary
Frequent HIV testing among persons at increased HIV risk is crucial for achieving early diagnosis and prompt
antiretroviral therapy initiation – key steps to reducing morbidity and eliminating transmission. HIV retesting can
also support ongoing efforts to scale-up pre-exposure prophylaxis. Despite guidelines recommending frequent
retesting among adults at higher risk, studies from sub-Saharan Africa suggest that retesting occurs
infrequently.
Behavioral economics provides insights into why people may not engage in behaviors like HIV retesting. Low
HIV retesting stems from structural factors (e.g. stigma and opportunity costs), as well as various biases and
heuristics in people’s beliefs and behavior, constraints in attention, and reliance on incorrect mental models.
Behavioral economics has also identified low-cost interventions (“nudges”) that effectively account for these
features of behavior. Building on our prior work that has identified barriers to HIV retesting, we have applied a
Behavioral Design framework to select nudges that are effective in addressing the psychological underpinnings
of each barrier to retesting. We will adapt the nudges to HIV retesting and local contexts through a participatory
prototyping approach that brings together scientists and end users. We will then conduct a large-scale, multi-
arm field experiment that features individual randomization and tests many different nudges. This “mega-trial”
approach has recently been used to test behavioral interventions to promote other health behaviors in the US
and offers many advantages over standard experiments that only test 1 or 2 interventions. With the same
outcome being examined in all study arms, mega-trials allow for direct comparison of different interventions.
Unlike 2-arm experiments, they also make it possible to identify which interventions work best for whom.
Leveraging the infrastructure of the SAPPHIRE trial of novel HIV biomedical prevention and treatment
approaches in Kenya and Uganda, we will enroll a large study population of persons at high risk of HIV to
conduct a mega-trial of low-cost behavioral interventions to promote HIV retesting. The project will have the
following aims:
AIM 1. Adapt behavioral economics interventions to promote HIV retesting using a participatory prototyping
approach in rural Kenya and Uganda. AIM 2. Determine the effectiveness of many behavioral economics
interventions to promote HIV retesting among high-risk adults in a multi-arm randomized trial. AIM 3. Estimate
heterogeneous treatment effects and identify optimal demand creation interventions.
The research we propose can accelerate the pace of discovery of interventions to increase HIV retesting and
transform future approaches to designing, testing and comparing interventions for health behaviors.

Public health relevance
Project Narrative Frequent HIV testing among persons at higher risk of HIV infection is crucial for facilitating early treatment initiation for those who have become HIV-positive and for supporting engagement in appropriate HIV prevention interventions for those who test HIV-negative. However, in many countries with high HIV prevalence there is insufficient retesting among persons at higher risk. This project will use innovative methods to adapt, test and compare multiple low-cost behavioral interventions to increase HIV retesting among adults in rural Kenya and Uganda, with the goal of identifying interventions that can be rapidly implemented at scale.